Targeting and DNA damage response in breast cancer

PROJECT SUMMARY/ABSTRACT: TARGETING DNA DAMAGE RESPONSE IN BREAST
CANCER
The increased genome instability caused by DNA repair defects can be exploited using synthetic lethal
approaches. For example, poly-ADP-ribose polymerase (PARP) inhibitors including olaparib have been
approved to treat breast and ovarian cancer patients harboring mutations in BRCA1 or BRCA2. These drugs
are thought to work by targeting defects in homology-directed repair (HR) of double-strand breaks (DSBs).
However, HR proteins, including BRCA1 and BRCA2, “moonlight” to regulate replication fork stability, and
there is increasing evidence that these replication fork functions can be important determinants of PARP
inhibitor outcomes independently of HR. Importantly, PARP inhibitor resistance is an increasing clinical
problem. Thus, defining clinically relevant resistance mechanisms, biomarkers of resistance, and ways to
overcome or prevent resistance are important research goals. This proposal addresses these issues both at
the mechanistic and patient levels. Our overall goal is to improve patient outcomes by defining the
mechanisms by which HR proteins regulate replication fork stability, understanding the contribution of
replication fork dynamics to PARP inhibitor sensitivity, and identifying drug combinations that can be used to
overcome resistance. We will use cell culture and patient-derived xenograft models to define mechanisms that
influence PARP inhibitor sensitivity, utilize patient-derived 3D-ex vivo organoid cultures to examine
mechanisms of PARP inhibitor resistance and explore rational drug combinations that can overcome
resistance mechanisms in clinical trials. Completing these studies will test the hypothesis that fork protection is
an important determinant of therapeutic efficacy of PARP inhibitors, identify therapeutic strategies to overcome
resistance and potentially provide a rationale for expansion of PARP inhibitor use for clinical investigation and
treatment.

Public health relevance
PROJECT NARRATIVE: TARGETING DNA DAMAGE RESPONSES IN BREAST CANCER Poly-ADP-ribose polymerase (PARP) inhibitors are useful in the treatment of cancers with defects in select DNA repair mechanisms. This project will test the hypothesis that fork protection is an important determinant of therapeutic efficacy of PARP inhibitors, identify mechanisms of resistance, and test therapeutic strategies to overcome resistance.